Admin Core

The burden of racial and ethnic health disparities is most evident in the southeastern United States, where
Black and Latino populations suffer the highest rates of cardiovascular disease, diabetes, obesity, hypertension,
cancer, and asthma. These chronic conditions are a primary cause of poor health, reduced quality of life, and
premature death, and account for more than 50% of health care expenditures. Despite substantial reduction of
some chronic diseases and risk factors over the last few decades, the Southeast continues to have the highest
number of potentially preventable deaths for each of the five leading causes of death.
Racial and ethnic minorities comprise 39% of the population of the Southeast (HHS Region IV), which includes
nearly 15 million African Americans and 9 million Latinos. Minorities in the Southeast fare worse on many health
indicators compared to other regions, in large part due to poor socioeconomic status, with more than 22% of
Southeastern residents living in poverty. Effectively addressing pervasive chronic disease disparities will require
interventions that consider the needs, priorities, and lived experiences of those disproportionately impacted.
Research teams with expertise in social, environmental, behavioral, and biological disciplines must collaborate
to develop and test multicomponent strategies aimed at the multilevel determinants that drive disparities.
The Administrative Core of the Southeast Collaborative for Innovative and Equitable Solutions to
Chronic Disease Disparities builds on existing, highly-productive, health disparities research collaborations
across multiple institutions in the Southeast, where efforts to mitigate chronic disease disparities have been
numerous, yet remain intractable among African Americans and Latinos. The Core will create a cross-institutional
structure, bringing together faculty from Vanderbilt University Medical Center, University of Miami School of
Medicine, and Meharry Medical College to:
Specific Aim 1. To develop and sustain a highly productive and efficient regional transdisciplinary
collaborative center that enables chronic disease disparities research to reduce disparities among African
American and Latino populations.
Specific Aim 2. To effectively expedite data integration, coordinate data harmonization, and share data
across research projects and pilot projects, and with the Coordinating Center.
Specific Aim 3. To facilitate Center operations through real-time data collection for continuous quality
improvement and support prospective monitoring and evaluation of Center activities.